Characterization of DNA repair in genomic and transcriptomic evolution of early lung carcinogenesis

Project Summary/Abstract
Lung cancer remains the leading cause of cancer-related mortality in the United States and is particularly
problematic in U.S. veterans, who are at an increased risk for lung cancer resulting in approximately 5,500
excess veteran deaths per year. This is largely due to the late stage at which lung cancer is diagnosed. However,
resection of pre-malignant and stage I non-small cell lung cancers (NSCLC) results in cure in most patients.
Current recommendations include screening high-risk patients for lung cancer by low dose computed
tomography (CT) of the chest due to a 20% relative risk reduction in mortality. However, debate exists on the
patient population most likely to benefit from this intervention. Pre-malignant lesions such as atypical
adenomatous hyperplasia and early lung adenocarcinomas, identified as nodules on chest CT, are often
indistinguishable from benign nodules, which can lead to aggressive diagnostic and therapeutic interventions,
and possibly harm, in patients with benign nodules or delayed diagnosis in those with NSCLC. Better diagnostic
and therapeutic targets are needed to detect and treat pre-malignant and early non-small cell lung cancers when
cure is likely. A better understanding of the mechanisms underlying transition from pre-malignant to frankly
malignant non-small cell lung cancers is essential for more accurate and timely diagnosis and ultimately
improved survival.
Genomic instability is a hallmark of cancer, and altered DNA repair pathways have been associated with
increased risk of lung cancers. The DNA repair protein, Xeroderma Pigmentosum Group C (XPC) gene
expression is decreased by chronic cigarette smoke in mice, and low XPC is identified early and often in human
lung adenocarcinomas. Our laboratory has discovered a critical role of XPC in protection against development
of cigarette smoke and carcinogen-induced lung adenocarcinoma development. We recently found that XPC
protects against histologic progression of mouse NTCU-induced lung squamous cell carcinomas. Our preliminary
data suggests progression of carcinogen-induced lung cancers in XPC deficient mice is associated with
increasing copy genomic complexity with higher histologic grade.
Based on these findings, we hypothesize that decreased DNA repair by XPC leads to pre-malignant
lesions with characteristic mutational and epigenetic signatures that predict progression to lung cancer. We
propose to study this in three aims, using human samples of pre-malignant and early NSCLC specimens
complemented by our well-established, XPC-deficient urethane lung adenocarcinoma progression model. In Aim
1, we will identify the impact of XPC in transition from pre-malignant to early and late adenocarcinoma pathologic
grades by performing single cell sequencing on specimens isolated from urethane-treated XPC deficient mice,
and confirm orthologous changes in humans using archived genomic data (NCBI Gene Expression Omnibus)
and mechanistic in vitro studies. In Aim 2, we will determine the mechanistic impact of immune evasion on lung
carcinogenesis using PD-L1 inhibitor, atezolizumab, in our mouse lung adenocarcinoma progression model, and
define characteristic immunogenotypic characteristics of atezolizumab-resistant lung adenocarcinomas. Finally,
in Aim 3, we will determine the impact of DNA repair on critical genomic and epigenetic changes in pre-malignant
and early human lung squamous cell carcinomas. DNA repair capacity, determined by host cell reactivation
assay, will be compared to bronchial epithelial cell dysplasia regression or persistence, and clonal genomic and
transcriptomic differences studied in dysplastic samples which progressed/persisted vs regressed. Studying the
mechanisms and genomic instability in early NSCLC development may allow for earlier recognition and novel
therapeutic targets in early non-small cell lung cancer.

Public health relevance
Project Narrative Lung cancer remains the leading cause of cancer deaths in the United States. This is particularly concerning for U.S. veterans, who are at an increased risk for lung cancer, from which 5,500 veterans die each year. Cancers often have abnormalities in their ability to repair DNA damage, which we believe are important to the development of mutations and other characteristic changes or lung cancer. Our laboratory has found a critical role of the DNA repair protein, Xeroderma Pigmentosum Group C (XPC) in protection against non-small cell lung cancer development. Using mouse carcinogen models of lung cancer and human lung cancer samples, we will look at the impact of DNA repair and XPC specifically on the earliest genetic changes and response to immunotherapy in non-small cell lung cancer. The ultimate goal is to find targets to identify non-small cell lung cancer earlier and treatments to prevent pre-cancerous lesions from progressing to lung cancer.